Clinical Centers for the NINDS NeuroNEXT(Network of Excellence in Neuroscience Clinical Trials) Consortium

The development of new therapeutics for patients with neurological disorders, which critically hinges on the efficiency of clinical trials, may be greatly facilitated by clinical trials consortia. The Network of Excellence in Neuroscience Clinical Trials (NeuroNEXT) aims to conduct multiple; scientiﬁcally sound, possibly biomarker informed, exploratory clinical trials of the most promising therapies. This proposal outlines the University of Miami's willingness and desire to continue to serve as a clinical trial site in the NeuroNEXT consortium. The experience and expertise of the investigative team at the University of Miami (UM), the commitment, infrastructure and investment of the Department of Neurology and the Miller School of Medicine in clinical and translational research, and the demography of the south Florida community uniquely position us to contribute to the mission of NINDS to reduce the burden of neurological disease that is borne by every segment of society. In addition to serving as an efficient and productive member of the NeuroNEXT consortium, we have the capacity and expertise to make a signiﬁcant contribution to ensuring successful enrollment in NINDS sponsored trials. The speciﬁc goals of our NeuroNEXT team are to continue service as an effective site in the NeuroNEXT network, leveraging our unique strengths and expertise for the beneﬁt of the broader network; and to continue development our clinical-translational workforce, providing young investigators and research staff with educational, training and career growth opportunities. Speciﬁc components of the research strategy focus on the efficiency of the process of clinical research implementation, education and training of new clinical investigators, recognition of the pivotal role that research coordinators play in the clinical trials process and a commitment to provide expertise and assistance to investigators engaged in other NINDS sponsored trials.

Public health relevance
Project Narrative The University of Miami Department of Neurology, which includes the Pediatric Neurology Division, will continue its service as a clinical trial site in the NeuroNEXT network, contributing high quality data from both adult and pediatric patients with a range of neurological diseases; and continuing to develop our clinical-translational workforce, providing young investigators and research staff with educational, training and career growth opportunities.